Growing up in a digital world: A synergistic approach to understanding media use in children ages 1-8 years

Project summary
Rapid growth in access to digital media is accompanied by a scarcity of research examining complex, real-time
family media context and sociocognitive outcomes, driven in part by a lack of comprehensive measurement
tools. To meet this challenge, the PI’s interdisciplinary research team developed a multi-method, scalable,
cost-effective toolkit called the Comprehensive Assessment of Family Media Exposure (CAFE) Toolkit. The
toolkit is designed to capture the content and context of early media exposure (Barr et al., 2020; Radesky et
al., 2020a). While this toolkit represents a substantial step forward in characterizing the family media ecology,
progress in understanding the effects of media exposure on child outcomes has also been limited by the lack
of large and representative longitudinal datasets, the difficulty of tracking quality of content in an ever-changing
media environment, and the lack of a mechanism to rapidly share and analyze results in a theoretically driven
manner. To overcome these limitations in the field, the overarching goal of this Research Program
proposal is to examine trajectories of media use - characterizing the context, content, and problematic
uses of media - in a diverse group of 1200 children aged between 1 to 7 years, assessing temporal
associations with emotion regulation and social competence using a cohort sequential design. The Research
Program includes three longitudinal studies, collecting data in three cohorts that span the entire age range (1-
3, 3-5, 5-7 year olds). New data collected during the project period will be compared to data collected before
and during the COVID pandemic using the same toolkit to examine how the pandemic altered media exposure
patterns and the relation between media exposure and socio-emotional outcomes. The work described in this
application will also produce research infrastructure to increase the efficiency of coding the quality of media
content, a bottleneck in the field. Finally, the data will be integrated, shared, visualized and analyzed in a
shared analytic research hub. The proposed research is significant because it would be the first synergistic
effort to utilize a comprehensive assessment of the family media ecology in a large, diverse, longitudinal
sample to identify antecedents of problematic media use in early childhood as well as specific media use
patterns that support social and emotional development in early childhood. The proposed work is innovative
because it (1) uses a multi-method, comprehensive assessment of the family media ecology; (2) applies an
ecological lens to study media effects and socio-emotional development within the family system; (3)
maximizes impact and efficiency with synergistic science; (4) streamlines content coding in an ever-changing
media environment; and (5) builds a collaborative platform for cleaning, integrating, and analyzing shared data
for reuse.

Public health relevance
Public Health Narrative The proposed research is relevant to public health because its findings would contribute to evidence-informed policies regarding family media ecology and be used to tailor interventions to the specific needs of individual families. These findings will also be relevant to ongoing policy debate surrounding the need for regulation of media content and for child-centered design to support healthy developmental trajectories in the digital age. Thus, the proposed research is relevant to NICHD’s mission as it pertains to early exposure to digital media and discovering how digital media use affects socio-emotional development in early childhood.